Geroscience Pathology and Cellular Histology

CORE D: SUMMARY Ikeno
In order to determine the impact of an experimental intervention on aging, it is essential that investigators
understand how an intervention alters pathological lesions that occur with age. Pathology increases
exponentially with advancing age and is largely responsible for age-related morbidity and mortality. Pathological
information also provides investigators with insight into the potential biological/molecular mechanism(s) of the
intervention. Furthermore, pathological assessment of old animals is necessary to help investigators determine
whether changes in the physiological and biochemical parameters measured are associated with or are
independent of any underlying pathological conditions. In addition, pathological analysis of young animals
provides investigators with information about genetic and pharmacological interventions that affect
development. Thus, it is essential to obtain accurate and thorough pathological assessments of aging in both old
and young animals. The Geroscience Pathology and Cellular Histology Core (GPCHC) will provide Project
investigators with detailed pathological analyses of lesions that occur with age in the animals. The GPCHC will
also provide investigators with cellular senescence characterization, histopathological, morphometric, and
immunohistochemical analyses of specific lesions and tissues (e.g., neoplastic lesions, glomerulonephritis,
gliosis in the brain, number and size of pancreatic islets, macrophage infiltration, and fat cell morphology in
adipose tissue) obtained from the mice studied. In addition, the GPCHC will develop a comprehensive database
of histopathological data and images of histopathology slides as a resource for: 1) trend analyses by the
investigators; and 2) a tissue archive containing paraffin and frozen blocks for analysis of samples by request
and for new morphological research. Furthermore, the GPCHC will provide investigators with histological
support. We will prepare paraffin-embedded and frozen blocks, make unstained paraffin or frozen sections, and
perform various histological staining techniques, including special staining.
These data will allow investigators to evaluate the effects of genetic and pharmacological manipulations on the
development of potentially fatal lesions and age-sensitive traits, and also provide information on whether the
biochemical/molecular changes observed in the projects are correlated to the histopathological changes in
specific tissues.